Administrative Core A

Core A: Administrative Core
Project Summary Abstract
The Administrative Core (Core A) will provide the structure for the overall program and will facilitate
interactions between the four Projects and the two other Cores. It will provide the scientific leadership for the
whole program and will guide the scientific exchange between all the components in the program. Core A will
also provide fiscal support for all projects and cores, and organizational support for the regular scientific
meetings of the project and core leaders, as well as host the external advisory board member visits. In
summary, Core A will promote programmatic interactions and foster the exchange of information and reagents
to ensure all aspects of a successful and productive program project.

Public health relevance
Core A: Administrative Core Project Narrative The Administrative Core (Core A) will provide the structure for the overall program and will facilitate interactions between the four Projects and the two other Cores. It will provide scientific leadership, facilitate scientific exchange between all components in the program and provide fiscal support for all projects and cores. In summary, Core A will promote programmatic interactions and foster the exchange of information and reagents to ensure all aspects of a successful and productive program project.